SEQUENCE DETERMINANTS OF PROTEIN STRUCTURE AND FUNCTION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We are studying how AAA+ enzymes including ClpXP, HslUV, and Lon catalyze ATP-dependent denaturation and subsequent degradation of specific target proteins.